Optimizing Respiratory Culture Practices for Mechanically Ventilated Children

Brief Summary
The number of mechanically ventilated children has grown 80-fold since the 1990s and ventilator-
associated infections (VAIs) are a leading complication. In the absence of a gold standard, there is clinical
uncertainty around the diagnosis of VAIs, and endotracheal aspirate cultures (EACs) are commonly obtained
as a tool to assess for VAI. Although EAC results are not specific for infection versus colonization, many
clinicians interpret bacterial growth in EACs as evidence of infection prompting treatment. Indeed, 50% of
antibiotics used in the pediatric intensive care unit (PICU) are for VAIs. Thus, over-use of EACs contributes to
unnecessary antibiotic treatment, compounding patient morbidity by promoting antibiotic resistance, antibiotic-
associated adverse events, and increased healthcare costs. Diagnostic stewardship programs promoting the
judicious use of EACs have significant potential to reduce unnecessary antibiotic use and improve the quality
of care for thousands of ventilated children. The goal of this study is to (1) define nationwide EAC practices
and identify optimal EAC practices in children with suspected VAIs, (2) assess key clinical outcomes after a
pilot program implementing interventions to improve EAC practices, and (3) identify facilitators and barriers of
EAC diagnostic stewardship programs to inform reproducible implementation strategies.
Dr. Sick-Samuels is a faculty member in Pediatric Infectious Diseases at the Johns Hopkins University
School of Medicine. She is committed to conducting patient-oriented research to develop, implement, measure
the impact of, and disseminate diagnostic stewardship programs to improve the care of complex hospitalized
patients. During this career-development award, she seeks to (1) develop expertise in implementation science
and patient safety and quality research, (2) analyze clinical outcomes used in patient safety and quality
research, (3) apply qualitative research methods to implementation science, and (4) prepare to conduct a
multicenter hybrid effectiveness-implementation trial. Her primary mentor, Dr. Aaron Milstone, has extensive
experience in clinical research and trials dedicated to prevention of antibiotic-resistance and healthcare-
associated infections in children. Her co-mentors, Dr. Sean Berenholtz, is a national and international leader in
patient safety and quality and prevention of ventilator-associated infections, and Dr. Jill Marsteller is a national
expert in implementation science researching determinants of successful implementation and dissemination of
evidence-based practices. Her advisors and collaborators have expertise in critical care medicine, infectious
diseases, patient safety and quality, implementation science, human factors engineering, and biostatistics. This
work will prepare her to develop an R01 proposal to conduct a multicenter effectiveness-implementation trial of
EAC diagnostic stewardship. With this mentored research, the resource rich environment of Johns Hopkins
University and the protected time to complete her training goals, Dr. Sick-Samuels will become an independent
investigator leading diagnostic stewardship and implementation science research.

Public health relevance
Public Health Relevance Increasingly, mechanically ventilated children are at risk for respiratory infections that are resistant to antibiotics. This proposal will support the career development and research of Dr. Sick-Samuels to advance the understanding of best practices to manage the evaluation of respiratory infections in mechanically ventilated children.